Streamlining PPI Inhibitor Discovery via Chemically Enhanced Phage Display

Streamlining PPI Inhibitor Discovery via Chemically Enhanced Phage Display
Project Summary
Protein-protein interactions (PPIs) are increasingly recognized as rewarding targets against which powerful
therapeutic drugs can be devised. This is perhaps best demonstrated by the remarkable success of the series
of anti-PD-1/PD-L1 antibody drugs developed to treat cancer. Despite the excitement, antibody-based drugs do
have a few limitations, including modest stability, lack of oral availability, poor tissue penetration and inability to
reach intracellular targets. Nevertheless, small molecule based PPI inhibitors remain scarce as large PPI
interfaces cannot be efficiently blocked by small molecule drugs. The shortcomings of these two major drug
modalities towards PPI inhibition rekindled people’s interest in peptides as an alternative modality. Peptides, as
a quintessential example of medium-sized molecules, would be able to forge large enough molecular contact to
block a PPI interface. On the other hand, they hold promise to overcome the limitations of antibody drugs,
particularly in terms of oral availability. The enthusiasm in peptide drugs was further fueled by the advent of
genetically encoded screening platforms such as phage display, which enables rapid screening of peptide
libraries. However, phage display often fails to reveal PPI inhibitors of desired potency, presumably due to the
overly simplistic structures of natural peptides in contrast to peptide natural product-based drugs. Over the past
few years, our group have made a number of exciting advances towards expanding the chemical space of phage
display libraries. First, we have developed novel warheads that elicit reversible covalent binding of amines such
as a lysine side chain. Second, we have successfully constructed covalent binding phage libraries and
demonstrated their utility in PPI inhibitor discovery. Third, we have developed highly efficient chemistries for
phage modification to give backbone rigidified peptide macrocycle libraries. These advances pave the road for
the further exploration of phage libraries of complex structured peptides. With this MIRA application, we seek to
develop novel phage libraries that display various covalent warheads and/or backbone rigidifying elements.
These phage libraries will be assessed for PPI inhibitor discovery against a panel of model proteins as well as
proteins that enable bacterial immune evasion or confer antibiotic resistance. Our proposed research will allow,
for the first time, pharmacologic interrogation of host-pathogen PPIs as potential targets of novel antibacterials.
Importantly, the proposed work will yield a powerful platform for discovering non-antibody based PPI inhibitors,
which will have broad impact far beyond the scope of this proposal.

Public health relevance
Streamlining PPI Inhibitor Discovery via Chemically Enhanced Phage Display Project Narrative Peptides have recently emerged as a new modality of therapeutics, which can enjoy the combined benefits of small molecule and antibody based drugs. This application seeks to develop new technologies, which will streamline the discovery of peptide therapeutics, particularly against the biological targets previously deemed undruggable by small molecule drugs.